TASK ORDER B-15: Model Development and Medical Countermeasure Evaluation

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.